EFFECT OF DIGITALIS ON LEFT ATRIAL FUNCTION IN IDIOPATHIC DILATED CARDIOMYOPATHY

The purpose of this research is to test the hypothesis that left atrial (LA) function is impaired in inpatients with congestive heart failure (CHF) due to idiopathic dilated cardiomyopathy (IDCMP) and that digitalis will improve LA function in this condition.